sodium tungstate dihydrate (STD) in Laboratory Animals for the National Toxicolog

The goal of this project is to evaluate the chronic toxicity and carcinogenicity of sodium tungstate dihydrate (STD) in rats and mice exposed via exposure in drinking water. Tungsten is a high production volume metal that is used in a variety of commercial applications, including military applications as a replacement for lead in small caliber ammunition and as a substitute for depleted uranium in armor penetrators. In addition, tungsten is found in dietary supplements and has potential clinical use as an antidiabetic therapy. 2-Year chronic toxicity and carcinogenicity studies of STD are in the in life phase. Keywords: toxicity, carcinogenicity, drinking water, sodium tungstate dihydrate